Role of Toll-Like Receptor Signaling in Cardiac Ischemia

Cardiovascular disease (CVD) is the number one killer in the United States. Every year about 735,000
Americans have a heart attack (myocardial ischemic injury). Of these, 525,000 are a first heart attack and
210,000 happen in people who have already had a heart attack. Cardiovascular endothelial dysfunction
contributes to myocardial ischemic injury. Endothelial cells express pattern recognition receptors (PRRs),
including Toll-like receptors (TLRs). PPRs recognize pathogen associated molecular patterns (PAMPs) and
endogenous (danger associated molecular patterns) ligands and initiate innate immune and inflammatory
responses which promote immune cell infiltration into the myocardium. Recent evidence suggests that
infiltrating macrophages and resident macrophages may have differential functions in mediating cardiac
injury or cardiac repair following myocardial infarction (MI). Therefore, cardiac macrophage function may be
critical for preservation of endothelial cell function, reducing myocardial ischemic injury and promoting repair
of damaged heart tissue.
During the last grant period, we have made a novel and exciting observation that endothelial cell specific
heat shock protein A12B (HSPA12B) is an important mediator of crosstalk between endothelial cells and
macrophages during MI. HSPA12B is a newly discovered member of the HSP70 family. It is predominantly
expressed in endothelial cells, and plays an important role in the induction of angiogenesis by activation of
phosphoinositide-3 kinase (PI3K)/Akt signaling. In our preliminary studies, we have discovered a novel role
for HSPA12B in the regulation of macrophage function and angiogenesis during MI. Specifically, we found
that endothelial cell specific HSPA12B deficiency (HSPA12B-/-) results in cardiac rupture which is associated
with increased infiltrating macrophages and reduced resident macrophages in the myocardium during early
phase of MI. In the late phase of MI, HSPA12B-/- mice exhibit worsened cardiac dysfunction and impaired
cardiac angiogenesis. In contrast, transgenic mice which overexpress endothelial HSPA12B show
significantly improved cardiac function and angiogenesis following MI. Thus, our findings indicate that
endogenous endothelial cell HSPA12B exerts protection against myocardial ischemic injury. Importantly, we
have discovered that HSPA12B is released from endothelial cells in exosomes that are uptaken by
macrophages where it regulates macrophage phenotypes, thus reducing inflammatory responses. In
addition, HSPA12B translocates into the nucleus accompanied by YAP/TAZ in endothelial cells and
promotes angiogenesis. YAP/TAZ are two important co-effectors in Hippo signaling and they play an
important role in the regulation of cell proliferation and angiogenesis. When taken together, our findings
indicate that endothelial HSPA12B plays an important role not only in endothelial cell proliferation and
angiogenesis but also in macrophage phenotypes during MI. Our preliminary data also suggests that
endothelial HSPA12B may mediate crosstalk between endothelial cells and macrophages for repairing
damaged heart tissue following MI.
This application is focused on deciphering the cellular and molecular mechanisms by which endothelial
HSPA12B differentially regulates macrophage phenotype and endothelial cell function during myocardial
ischemic injury. Based on the preliminary data, we hypothesize that “endothelial HSPA12B is a novel
effector for the protection against myocardial ischemic injury by differentially regulating macrophage
phenotype and endothelial cell function”. To critically evaluate this hypothesis, we propose the following
specific aims.
Specific aim 1. Define the mechanisms by which endothelial HSPA12B regulates the function of
infiltrating and resident macrophages during MI. Specific aim 2. Investigate the novel mechanisms by which
HSPA12B regulates cardiac repair and angiogenesis following MI. Specific aim 3. Evaluate the therapeutic
potential of HSPA12B in myocardial ischemic injury. The long term goals of this research are to elucidate the
cellular and molecular mechanisms of myocardial ischemic injury and to develop new and novel therapies to
ameliorate the morbidity and mortality associated with myocardial infarction.

Public health relevance
Narrative. Cardiovascular disease (CVD) is the number one killer in the United States. Every year about 735,000 Americans have a heart attack (myocardial ischemic injury). Of these, 525,000 are a first heart attack and 210,000 happen in people who have already had a heart attack. Despite years of intensive research, there is still much that we do not know about the mechanisms of the disease. It is well known that endothelial dysfunction is associated with myocardial ischemic injury (heart attack). Endothelial cells express a group of receptors called pattern recognition receptors (PRRs). These receptors can bind with a group of molecules called pathogen associated molecular pattern (PAMPs) and lead to inflammatory response. Hyper-inflammatory response will promote immune cells moving to the heart at where they will cause heart cell damage. Therefore, it is clear that a better understating of the molecular mechanisms leading to heart damage during heart attack is essential in developing adjunctive therapies that could decreases both morbidity and mortality of heart attack. These studies will provide a mechanistic understanding of a endothelial cellular molecule that plays a critical role in mediating an interaction (crosstalk) between endothelial cells and immune cells (monocytes/macrophages) during heart attack. To the best of our knowledge, this is a new and novel role for an endothelial cellular molecule that plays a critical role in in protection against myocardial ischemic injury. More significantly, our studies will have practical significance in that they may lead to the development of novel treatments that could decrease morbidity and mortality in heart attack patients.